A pilot trial of health coaching to improve functioning and reduce suicide risk among reintegrating Veterans

Background: Veterans’ suicide risk is highest during the first year after military service separation. This
heightened suicide risk has been associated with difficulties reintegrating into civilian life. Deficiencies in role
functioning (knowing who you are and where you are heading in life) is one of the most commonly reported
challenges during reintegration. Role functioning is critical for optimal functioning in adult life roles (e.g.,
employment) and it is predictive of suicidal ideation and attempts. However, there are no evidence-based
interventions that address role functioning to reduce suicide risk and improve functioning in adult life roles.
Significance: The importance of reaching Veterans proximal to service separation outside of traditional clinic
settings is clear; Veterans’ risk for suicide is highest within the first year of service separation and Veterans are
not well-connected to VA care or other services during this time period. Health coaching is a non-clinical health
behavior change modality that is designed to improve role functioning and can be delivered virtually (via
telephone/video). Although health coaching has been embraced by the Veterans Health Administration (VHA),
no rigorous, fully powered trials have examined the effectiveness of health coaching. Virtually-delivered health
coaching may be an easily scalable, low-cost approach to reach reintegrating Veterans outside of clinic
settings to reduce suicide risk and improve functioning in adult life roles.
Innovation: No studies have examined the use of health coaching among reintegrating Veterans outside of the
clinic setting. This study’s strategic use of virtually-delivered health coaching builds on VHA’s investment in this
non-clinical modality that has the potential to reduce suicide risk during a high-risk transition period.
Specific Aims: This pilot study will 1) Examine the feasibility of study procedures and acceptability of the
health coaching intervention among reintegrating Veterans; 2) Evaluate measures of mediators and outcomes
for suitability in a future confirmatory efficacy trial; and 3) Determine barriers and facilitators of implementation
of health coaching among reintegrating Veterans.
Methodology: We will enroll a national sample of 94 Veterans within three months of military service
separation and follow them for 9 months, capturing their first year of separation. Participants will be
randomized to health coaching + enhanced usual care (EUC) or EUC only. The intervention group will receive
up to 12 health coaching sessions over the phone or via video (per participant preference). All participants will
receive a booklet about VA benefits and services, organized by functional domains, as an enhancement to
“usual care.” Participants will complete self-report assessments at baseline, mid-intervention (month 2), post-
intervention (month 4), and follow-up (month 9). Approximately 30 participants will complete qualitative
interviews on their experiences with health coaching and intervention coaches will complete exit interviews on
their experiences delivering coaching. VHA administrative data will be used to ascertain VHA care utilization.
We will use study log data, a satisfaction measure, and qualitative interviews to examine feasibility of the study
methods and acceptability of the intervention, including potential harms. Evaluation of measures for inclusion in
a future efficacy trial will involve characterizing typical variation, descriptive analyses of within-person change
across time, and adjusted estimates of treatment effect sizes with 95% confidence intervals. To inform barriers
and facilitators to implementing virtually-delivered health coaching we will analyze Veteran qualitative
interviews and coach exit interviews using a primarily descriptive thematic analysis approach.
Next steps: Data gathered in this study will inform design of a subsequent efficacy trial of virtually-delivered
health coaching among reintegrating Veterans and future implementation strategies. This line of research will
inform the strategic use of virtually-delivered health coaching as a population-based rehabilitation approach to
reduce suicide risk and improve functioning in life roles among reintegrating Veterans.

Public health relevance
The first year after military service separation is a critical time to reach reintegrating Veterans, as the suicide rate among Veterans is highest during this first year. One of the most common challenges reintegrating Veterans face involves redefining who they are and where they are going in life as civilians, called role functioning, which impacts their functioning in adult life roles. Deficits in role functioning are also strongly associated with suicide risk. However, no evidence-based interventions address role functioning to reduce suicide risk. The proposed study will examine the acceptability of virtually-delivered health coaching, an understudied health behavior change modality, among reintegrating Veterans during their first year of service separation. We will also gather data to inform study design, including measure selection, for a subsequent fully powered efficacy trial of health coaching. This study will also inform future implementation needs for using health coaching as a population-based rehabilitation approach to suicide prevention.